(2/2) Statins to Prevent Cancer Associated Venous Thromboembolism (STAT-CAT): DCC

STAT-CAT Project Summary / Abstract (maximum 30 lines)
Oncology patients are at high risk for life-threatening venous thromboembolism (VTE) yet rarely receive
anticoagulant prophylaxis due to bleeding risks. Thus, effective prophylaxis in oncology requires a
method to reduce VTE without increasing hemorrhage. The primary aim of the proposed Statins to
Prevent Cancer Associated Venous Thromboembolism (STAT-CAT) trial is to test whether rosuvastatin
20 mg daily for 12 months compared to placebo can safely prevent VTE in patients with newly
diagnosed or recently relapsed cancer who are at increased thrombotic risk, are not planned to be
anticoagulated, and who neither take nor otherwise qualify for statin therapy. Randomized trial data
strongly support the core STAT-CAT hypothesis; as independently demonstrated in both the large-scale
JUPITER and HOPE-3 trials, random allocation to rosuvastatin as compared to placebo resulted in a
47% reduction in VTE risk (HR 0.53, 95%CI 0.37-0.75) without any increase in bleeding. STAT-CAT is
also supported by mechanistic studies which demonstrate decreased prothrombotic potential in those
taking rosuvastatin through lipid independent pathways that include anti-inflammatory effects. STAT-
CAT will enroll up to 4000 participants with recently diagnosed or relapsed cancer who have moderate-
to-high VTE risk using an innovative pre-screening computable phenotype tool that will efficiently
enable study coordinators to electronically pre-define potential trial participants at all sites in an
identical manner while reducing subjectivity and enhancing applicability and generalizability. STAT-CAT
will enroll through a proven “hub-and-spoke” engagement plan with committed high-volume academic
cancer centers who have strong community partnerships to ensure a broad and generalizable tumor
base with adequate representation of both sexes and of underrepresented populations; these sites see
more than 75,000 STAT-CAT eligible patients annually. The primary endpoint of STAT-CAT is the
incidence of pulmonary embolus, deep vein thrombosis of the upper or lower extremities, or fatal VTE
during 12 months of active therapy or matching placebo. Secondary and tertiary aims include the
impact of rosuvastatin on the composite rate of venous and arterial thrombosis, as well as evaluating
safety with a focus on bleeding, transaminitis and myositis. Streamlined trial operations and pragmatic
participant follow-up assessments will be used to minimize site burden while allowing virtually all other
trial activities, including drug delivery, to be performed centrally in a consistent and cost-efficient
manner. We believe the likelihood is high that generic rosuvastatin can significantly reduce rates of VTE
in an oncology setting with no increase in bleeding; if successful, STAT-CAT will markedly improve
thrombotic outcomes for large numbers of oncology patients with a safe and inexpensive intervention
that avoids the hemorrhagic complications of conventional anticoagulation.

Public health relevance
STAT-CAT Project Narrative (3 sentences) Patients with recently diagnosed cancer are at high risk for life-threatening venous thromboembolism (VTE) yet are also at increased risk for bleeding and thus rarely receive conventional anticoagulant prophylaxis. In the general population, two large placebo-controlled trials have shown rosuvastatin to reduce VTE rates by 47 percent without any increase in bleeding. The Statin to Prevent Cancer Associated Venous Thromboembolism (STAT-CAT) trial will thus test whether rosuvastatin 20 mg daily for 12 months compared to placebo can safely prevent VTE in patients with a broad range of recently diagnosed cancers who have increased thrombotic risk, are not receiving anticoagulation, and who are not otherwise eligible for or already taking statin therapy.